iPSC-derived macrophages as a model to study the genetic basis of inter-individual variation in immune responses to pathogens

Project Summary
Infectious diseases have always been a major health problem throughout the world, imposing a strong selective
pressure on the human genome. Despite the recent advent of vaccines and antibiotics, infectious diseases cause
near1y 15 million deaths every year. Although a significant proportion of inter-individual variation in susceptibility
to microbes can be attributed to environmental factors, a substantial portion is also due to host genetic factors.
The importance of host genetic factors on susceptibility to infectious diseases has been shown by comparative
studies involving twins and adopted persons. Yet, very little is known about the underlying genetic factors
contributing to differences in susceptibility to infectious diseases at the population level. In addition, the level of
epigenetic variation across individuals and populations, and how such variations might impact susceptibility to
infectious agents remains unknown. By combining expertise in functional genomics, computational biology,
human immunology, population genetics, and infectious diseases, we aim to identify genes and regulatory
pathways that contribute to variability of immune response to two of the deadliest infectious agents of our days:
Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis (TB) in humans, and influenza virus.
Specifically, we propose to leverage the power of induced pluripotent stem cells (iPSC)-derived macrophages
to: (i) characterize inter-individual and inter-population variability in immune responses to infection with (Mtb)
and influenza viruses in humans; (ii) study the contribution of epigenetic variation to inter-individual variation in
immune responses; and (iii) map quantitative trait loci (QTL) that are associated with variation in the immune
response to infection with Mtb and influenza, and evaluate the impact of natural selection at shaping their allele
frequencies across populations. This work will yield unprecedented insight into the genetic and epigenetic basis
underlying inter-individual variation in immune responses to two of the deadliest infectious agents of our days.
Combined, these efforts will establish innovative, novel, and empirically grounded "immune profiling" strategies
for identifying those most at risk for infectious diseases and other immune-related disorders, which together
constitute one of the largest health burdens facing modern human populations.

Public health relevance
Project Narrative Humans show remarkable variation in response to the same infectious agents. Yet, our understanding of the genetic and epigenetic determinants of this variation is still at an early stage. This project will identify host determinants of inter-individual and ancestry-associated variation in immune responses to live pathogens.